Brain networks for reading in stroke alexia and typical aging

PROJECT SUMMARY/ABSTRACT
The ability to read is fundamental to living in modern society. Loss of reading ability due to stroke, called
alexia, likely affects over a million Americans at any given time and causes difficulty performing many daily life
functions. To improve diagnosis and treatment of alexia, we must understand the neurocognitive basis of
reading deficits after stroke. However, prior small-scale studies using broad diagnostic categories and older
neuroimaging methods have yielded only general lesion-behavior associations in alexia. Here, we propose the
largest study to date of both alexia and typical reading in older adults, using detailed measures of reading
ability and the most advanced multimodal neuroimaging methods available to test a new neurocognitive model.
Reading relies on brain networks that evolved for speech and language processes, but neurocognitive
models of reading have not yet incorporated recent advances in our understanding of these networks. We
propose a new model of Reading Integrated with Speech and Semantics (RISS) that provides a more specific
neurocognitive architecture for reading than prior models. We hypothesize that lesions of specific RISS
network processors and connections account for specific reading deficit patterns after stroke, and that
restoration of the injured RISS pathways or compensation in uninjured pathways underlie alexia recovery.
Although brain networks for reading have been extensively mapped in typical and atypical young
populations, stroke tends to occur in the aging brain and in people of low education and socioeconomic status
(SES) who are too often left out of cognitive neuroscience research. Pathological patterns of reading in alexia
are also observed to a lesser degree in typical readers, and age, education and SES are all known to affect
reading abilities. Therefore, alexia can only be fully understood by examining how these factors relate to
reading behavior and the brain in typical older adults, and referencing reading deficits to this personal context.
In the first study of this project, we will collect an extensive battery of reading and language tests along with
advanced multimodal MRIs in 100 older adults demographically matched to stroke survivors. We will test
hypotheses based on RISS and examine how age, education, and SES relate to both behavior and the brain.
We will freely disseminate all testing materials and both behavioral and imaging data to facilitate further
research in this area. In the second study, we will perform the same behavioral battery in 200 chronic stroke
survivors prospectively selected based on lesion attributes from a new imaging database of thousands of
stroke survivors. We will model the effects of the lesions on processors and connections in RISS and test
brain-behavior hypotheses using lesion-network mapping analyses. In the third study, we will collect detailed
behavioral data and multimodal MRIs in 50 stroke survivors during the subacute period and again 12 months
later to test hypotheses regarding mechanisms of alexia recovery based on RISS. This project will substantially
advance our understanding of the neurocognitive basis of reading in both alexia and typical aging.

Public health relevance
PROJECT NARRATIVE Loss of reading ability due to stroke, called alexia, likely affects over a million Americans at any given time and causes difficulty performing many daily life functions. Understanding the brain and cognitive basis of alexia could improve diagnosis and treatment of this important disorder, but modern methods and larger sample sizes are needed to address this gap in knowledge, along with an improved understanding of the brain and cognitive basis of reading in typical older adults in whom stroke is most common. In this project, we will perform a large- scale behavioral and brain imaging study of stroke survivors and typical older adults to improve our understanding of the brain and cognitive basis of reading in both of these groups.